USE OF RECOMBINANT HUMAN THYROID STIMULATING HORMONE IN A THYROID CANCER PT

The objective of this study is to use human recombinant human thyroid stimulating hormone, Thyrogen (Genzyme Corporation), an investigational drug, as a compassionate use therapy in a patient with metastatic papillary cancer of the thyroid.